Viral Protein R (Vpr) in HIV-associated Brain Neuroinflammation and Neurotoxicity

This proposed project has direct relevance to Veteran healthcare because it addresses current VA’s research
priority on how HIV-1 infection causes brain damages that affect Veteran’s mental health including HIV-
associated neurocognitive disorders (HAND) and suicide. There are about 37 million people currently living with
HIV/AIDS worldwide. Successful treatment with combinational antiretroviral therapies (cART) can eliminate
active replicating viruses and prolong patients’ lives to nearly normal lifespans. However, the new challenge
faced by more than half of those HIV-infected and aging patients is the chronic CNS neuroinflammation, which
leads to various HAND. While severe and progressive HAND has decreased significantly due to cART, chronic
HANDS often persists, resulting in high rates of delirium, dementia and depression that could lead to suicide.
Indeed, “the risk of suicide mortality in HIV-infected persons is 3-5 times higher than in HIV-uninfected
counterparts”. Nevertheless, the mechanism of neuropathogenesis underlying HAND is not well understood.
HAND is typically characterized by HIV-mediated glial neuroinflammation and neurotoxicity. Interestingly, the
severity of some HAND does not always directly correlate with the levels of HIV, but rather with glial activation,
suggesting other HIV-associated factors, not the whole virus per se, contribute to those HAND. HIV-1 viral protein
R (Vpr) might be one of those viral factors, because Vpr induces neuroinflammation and causes neuronal
apoptosis. Moreover, in the absence of active viral replication under cART, Vpr can be found in CNS-associated
cells because 1) it can be released directly from viral particles; 2) it crosses the blood-brain barrier that can be
taken up by glia and neurons; and 3) it triggers viral transcription of latently-infected cells by binding to LTR
promoter. Despite these strong evidences indicating a prominent role of Vpr in HAND, how exactly Vpr
contributes to HAND remains elusive. The objective of this proposal is to study the specific role(s) of Vpr in
activation of host neuroinflammation, neurotoxicity and viral reactivation, as well as its contribution to HAND.
Through our pilot studies, we discovered correlations between HIV expression and activation of
proinflammatory markers (TLR4, TNFα, NF-κB and the Sur1-Trpm4 channel) in astrocytes of HIV-infected
postmortem human and transgenic mouse brain tissues. Furthermore, Vpr alone activate the same set of
markers in glial cells. The connection between Vpr and the Sur1-Trpm4 channel could potentially be significant
for understanding HAND because this channel is a key neuro-regulator involved in various neurocognitive brain
conditions. Indeed, inhibition of the channel by a repurposed and FDA-approved drug glibenclamide reduces
Vpr-induced apoptosis and improves other neuroinflammatory brain conditions. Thus, our pilot studies may have
revealed a novel mechanism of HAND involving Vpr-induced activation of the Sur1-Trpm4 channel. Therefore,
we hypothesize that Vpr contributes to HAND by TLR4/MyD88- and/or TNFα-mediated NF-κB activation, which
in turn upregulate the Sur1-Trpm4 channel leading to neuroinflammation and neurotoxicity. Alternatively, Vpr-
induced HAND is contributed collectively by NF-κB and Sur1-Trpm4-mediated neuropathologic effects. We
further hypothesize that target-specific inhibition of key regulators such as the Sur1-Trpm4 channel mitigates
Vpr-induced HAND. We will test these hypotheses with three specific aims (SA). SA1: delineate molecular
mechanism of Vpr-induced neuroinflammation, neurotoxicity and viral reactivation in primary astrocytes; SA2:
test the functional link of Vpr with the Sur1-Trpm4 channel, its interaction with NF-kB and its contribution to Vpr-
induced HAND; and SA3: evaluate the effects of genetic and pharmacologic inhibitions of the Sur1-Trpm4
channel on Vpr-induced HAND by using knock-out mice and by target-specific therapeutic drugs such as
glibenclamide. Successful completion of this project will provide novel insights into 1) the molecular mechanism
and contribution of HIV-1 Vpr to HAND, 2) the functional link between Vpr and the Sur1-Trpm4 channel and its
contribution to HAND, and 3) the feasibility of treating Vpr-related HAND with the therapeutic drug glibenclamide.

Public health relevance
HIV/AIDS affects about 37 million people worldwide including Veterans. Successful anti-HIV treatments can eliminate nearly all active viruses and prolong patients’ lives to nearly normal lifespans. However, the new challenge faced by aging patients is chronic neuroinflammation in the brain, leading to various HIV-associated neurocognitive disorders (HAND) that are found in more than 50% of HIV-infected individuals. Even under effective antiviral therapies, chronic HAND persists with high rates of delirium and dementia that can lead to suicide. According to a VA report, “the risk of suicide mortality in HIV-infected persons is 3-5 times higher than in HIV-uninfected counterparts.” What causes HAND is not well understood. Through our pilot studies, we have linked a HIV protein Vpr to HAND, and discovered a novel mechanism involving activation of the Sur1-Trpm4 channel. The goal of this proposal is to study the specific role(s) of Vpr in neuroinflammation, neurotoxicity, and viral wakening; as well as the possibility of treating HAND with a repurposed FDA-approved drug glibenclamide.